Developmental Funds

PROJECT SUMMARY/ABSTRACT – DEVELOPMENTAL FUNDS
Since the prior review, UWCCC has appointed a new Director, who has codified a Strategic Operating Plan.
This plan will serve as UWCCC’s road-map for prospective development investments. The flexibility of CCSG
Developmental Funds provides the UWCCC Director with the ability to support evolving opportunities that
support the goals established by the leaders of UWCCC. Future investments in faculty start-up packages,
pilots, and state-of-the-science shared resources are critical to executing our goals and priorities.
Developments funds will catalyze efforts to advance cancer imaging and biomarker research, further promising
innovative therapies, and strengthen population health research.
UWCCC commits CCSG development funds for start-up support for faculty candidates who provide the most
promising opportunities for significant contributions to the Scientific Programs of UWCCC. In concert with the
priorities established for future development, candidates will be chosen because of their promising potential to
conduct cancer research leading to translation, or to contribute to applied research resulting from translation.
During the current grant period, UWCCC contributed $4.7M ($500K CCSG) towards the recruitment of 31
faculty. These faculty have been awarded a total of approximately $73M in sponsored research funding.
Among the 31 faculty recruitments; 23 hold peer-reviewed cancer funding; 9 hold NCI funding; 14 filled active
leadership roles; 2 are Division or Department Chairs; 14 are placed in UWCCC space; and 28 are active
Shared Resource users.
UWCCC CCSG developmental funds provided resources of $2M for 92 pilot projects. Going forward, pilot
projects will be essential in providing resources, which catalyze inter-and-intra programmatic discovery.
Building on the recent success of a Head and Neck SPORE award, we anticipate development pilot funds
focusing on Breast and Prostate cancer opportunities for program projects or SPORE applications.
Funds for developing shared resources will focus on a clinical imaging core necessary for therapeutic studies
and increasing usage of standard tumor imaging response assessments supervised by board certified
radiologists and nuclear medicine physicians. In addition, we will use funds for a state-of-the-science
Metabolomics Core. Going forward the center will place greater emphasis on inter-programmatic activities and
initiate a scientific retreat meant to stimulate these opportunities.